Paneth Cell Secreted Effectors in Mucosal Innate Immunity

The immune system of mucosal tissues must effectively protect the host from pathogen invasion, while facilitating homeostatic interactions with a diverse colonizing microbiota. A clear understanding of the key molecules and mechanisms that achieve this delicate balance remains incomplete, leaving a gap in critical knowledge. Paneth cells of the small intestine secrete large quantities of proteins and peptides into the lumen that mediate both interrelated functions of host defense and maintenance of homeostasis. Compelling published evidence from many laboratories, including ours, suggests that defective Paneth cell function increases susceptibility to chronic inflammatory bowel disease (IBD) and to enteric pathogens. This investigation will focus on a secreted protein that our preliminary data suggests is among the most abundant secretory proteins of human Paneth cells, an understudied intestinal lectin named intelectin. Intelectin orthologs widely span the animal Kingdom, from mammals to the invertebrate sea squirts. Recent published data demonstrate that intelectin has molecular pattern binding activity characteristic of the innate immune system, in that it binds to carbohydrates found on a variety microbes - through interaction with exocyclic 1, 2 diols - but does not bind to host carbohydrates because of steric hindrance. Our preliminary data identify qualitative and quantitative aberrations of the two isoforms of intelectin (ITLN1 and ITLN2) in small intestinal specimens from individuals with ileal Crohn's disease (CD) compared to controls. While statistically significant, the mechanisms that may tie these changes to impaired innate immunity in CD are unknown and will be investigated. Our hypothesis, based on published and preliminary data, is that intelectin is a critical mediator of host-microbe interaction in the intestine. Aim 1 will determine the relative expression levels of ITLN1 and ITLN2 in small intestinal CD and control specimens, and biochemically characterize intelectin isolated from human small intestine. Aim 2 will investigate the in vitro activity of intelectin isoforms in vitro. Aim 3 will establish innate immunological consequences of intelectin expression using newly generated C57BL/6 Itln-/- mice. Our goal is to elucidate a fundamental understanding on the role of intelectin in mucosal protection, and in so doing, fill a void in our understanding of a conserved, highly abundant secretory protein of human Paneth cells. Successful completion of these studies will likely have broad impact on our mechanistic understanding of innate immunity in the small intestine.

Public health relevance
Intelectins are understudied molecules found throughout nature that appear to provide host defense against pathogenic microbes, and may contribute to mucosal homeostasis in the human small intestine. Relatively little is known about the expression and mechanism of the two isoforms of Intelectin (ITLN1 and ITLN2) that are produced by specialized secretory (Paneth) cells of the human small intestine. These proposed studies will provide a clearer understanding of the biological function of intelectin and should yield insight into why Paneth cell dysfunction is associated with susceptibility to infectious disease and pathogenesis of chronic inflammatory disease.